Deep learning for prediction of Mild Cognitive Impairment and Dementia of the Alzheimer's type

ABSTRACT
Alzheimer’s disease and associated dementias are major public health challenges with a multifold increase in
prevalence expected in the coming decades. Alzheimer’s disease is increasingly recognized as having network-
level effects and interactions. In this project, we will develop a deep learning model to learn the latent
representation of functional neuroimaging, in order to disentangle the underlying sources and better reconstruct
the data.
Deep learning approaches in fMRI have faced a common challenge on generalizability and explainability. To
address these issues, the system will learn representations that can be decoded and interpreted as spatial
patterns and temporal dynamics of brain networks; and be readily generalizable to different subjects, brain
states, behavioral tasks, and disease conditions without a need to redesign or retrain the system from scratch.
The proposed focus on Alzheimer’s disease is the first step in exploiting this notion for clinical application.
We will leverage both publicly available large data (e.g., Human Connectome Project-Aging, Alzheimer’s Disease
Neuroimaging Initiative) as well as the well-characterized longitudinal cohort of the NIA P30-funded Michigan
Alzheimer’s Disease Research Center (MADRC); this cohort undergoes annual neurological and
neuropsychological evaluations and is particularly unique since it consists of ~45% African Americans. This
research is particularly relevant for ethnic minority populations since African Americans are almost twice as likely
to develop cognitive decline as Non-Hispanic white Americans; yet most of what has been learned about
dementia biomarkers is based on study samples that are primarily Non-Hispanic white Americans.
The overall goal of this project is to develop an enhanced deep learning model for improved data representation,
subtype classification and prediction of clinical behavioral measures and apply it to the domain of mild cognitive
impairment (MCI) and dementia of the Alzheimer’s Type (DAT).

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease and associated dementias are major public health challenges with a multifold increase expected in the coming decades. This study will develop an advanced deep learning MR analysis technique to better classify and predict the manifestation of Alzheimer’s dementia. The project has considerable potential to immediately address multiple key knowledge gaps in disease etiology and how it manifests in minority ethnic groups.